Tubulin Genes in Mammalian Forebrain Development

ABSTRACT
Variants in tubulin genes cause many severe malformations of human forebrain development
and these are called “tubulinopathies.” Multiple tubulin genes are highly expressed in the
developing brain and the human genetics studies now show there is a spectrum of disease
arising from tubulin mutations. Completed sequencing of multiple mammalian genomes
reveals there are multiple highly similar tubulin genes. These include the genes of the TUBA1*
group (TUBA1A, TUBA1B, TUBA1C) and the TUBB2* group (TUBB2A and TUBB2B). All human
tubulin mutations identified to date with malformations of cortical development are de novo,
heterozygous missense mutations. This suggests that a tubulin monomer protein is being
produced, but acting in an inappropriate manner within the cell. We have performed the only
complementary loss of function studies to date on any of the mouse Tuba1* or Tubb2* genes. A
deeper understanding of the etiology of the human malformations and requirements for
individual tubulin genes is essential to any therapeutics. The overall objective of this application is
to understand why and how tubulin mutations cause malformations of cortical development.
Our central hypothesis is that the human tubulin missense, de novo variants cause cortical
malformations through dominant-negative effects on microtubule function and/or tubulin monomer
protein-protein interactions. We will test this central hypothesis and accomplish the goals of this
application by pursuing the following three specific aims: (1) use novel epitope-tagged alleles to
determine the unique sites of expression for Tuba1 and Tubb2 genes, (2) determine cellular and
embryonic molecular mechanism(s) of phenotypes caused by a series of mutations in Tuba1a/b/c,
and (3) determine the unique requirements for Tubb2a and Tubb2b for mouse neural
development. We expect these studies to have the following outcomes: First, we will determine
for the first time the cellular expression patterns of a series of tubulin genes crucial for
mammalian nervous system development. Second, we will determine the levels of genetic
redundancy within the Tuba1* and Tubb2* gene families. Third, we will understand how human
pathogenic mutations in tubulin genes lead to complex malformations of cortical development.
By answering some of these basic questions about tubulin biology, we are poised to
contemplate the best therapeutic intervention(s). Recent studies have demonstrated that
treatments of cortical malformation syndromes in an already malformed brain can ameliorate some
symptoms. Thus, a greater understanding of the tubulinopathy developmental disorders could
open some promising doors to fruitful treatments.

Public health relevance
NARRATIVE The proposed research is relevant to public health because many birth defects involving the brain are due to mutations in tubulin genes. The benefits of this study include a deeper understanding of the biology of several of these tubulin genes and a demonstration of functional redundancy within the gene family. This knowledge has the potential to guide future gene therapy of brain malformations due to mutations in tubulin genes.